Testing a Dynamic Spatiotemporal Normalization Framework for Human Vision

PROJECT SUMMARY/ABSTRACT
Our perception at a given point in time does not only depend on instantaneous visual input, but also on what
happened before and after. Yet most research on visual perception has focused on static image processing, and
we lack unifying theoretical frameworks for understanding how vision unfolds in time. One promising theoretical
building block is normalization. Normalization is a canonical computation in sensory systems that plays a key
role in highlighting salient changes in visual scenes. Whereas the normalization framework has been vetted
extensively in the spatial domain, extension of the normalization framework to the time domain has been limited.
In addition, although spatial normalization is thought to be regulated by spatial attention, how temporal attention
(attention to moments in time) interacts with temporal normalization has not been investigated. In this proposal,
we introduce and test a flexible new dynamic model of spatiotemporal normalization, which has the potential to
unify disparate effects of contextual and attentional modulation across space and time under a single
computational framework for dynamic vision. The proposed behavioral and fMRI experiments are designed to
test several predictions of the computational theory. These include effects of preceding and following temporal
context on perception and neural responses, the dependence of temporal context effects on the time constants
of temporal receptive fields, and the tight relationship between temporal attentional modulation and temporal
normalization. The high-quality linked behavioral and fMRI datasets we collect will not only allow us to fill in gaps
in our knowledge about basic aspects of temporal processing, but will be suitable for future researchers seeking
to test dynamic vision models. We expect that the basic knowledge gained from these studies will provide a
necessary foundation for the development of diagnostic tools and treatments for clinical disorders that involve
deficits in central visual processing, especially in the context of dynamic, active vision.

Public health relevance
PROJECT NARRATIVE What we perceive at one moment in time depends not only on instantaneous visual input, but also on what occurred before and after—as well as on our fluctuating attentional state. Here we develop a theory of visual and attentional computations across space and time and test it with behavioral and fMRI experiments. The results will reveal basic mechanisms of dynamic visual perception and attention, which should be broadly applicable to understanding visual function in health and disease.